Complex systems approaches to identify policy levers to reduce racial/ethnic disparities in diet and obesity in cities

PROJECT SUMMARY
Racial/ethnic disparities in diet and obesity are remarkably consistent across U.S. cities. First, we will use
group model building to systematically engage academic, policy, and community stakeholders to build capacity
for systems thinking, develop and refine a “map” of the multilevel factors that drive diet disparities, and identify
policy levers to reduce diet disparities in cities. The need for this work is motivated by the lack of an existing
conceptual framework that explicates mechanisms via which obesogenic environments and systematic
structural disadvantage disproportionately affect minorities and lead to disparities. Previous research and
existing conceptual frameworks have identified myriad influences on diet among the general population, but a
more specific conceptual framework can advance understanding of social, environmental, and policy factors
that work in combination to constrain healthy food choices of Blacks, Latinos, and other racial/ethnic minorities.
Second, we will implement an agent-based simulation model (ABM) to examine how residential segregation,
the inequitable distribution of food outlets, the lower price of unhealthy foods, and income inequality work in
combination to constrain food choices of racial/ethnic minorities and lead to diet and obesity disparities. The
ABM bridges lines of research conducted by our group and others that have used ABM to examine how food
access and food prices separately affect diets. By integrating these separate modeling paradigms, we can
examine how diet disparities emerge due to intersecting disadvantage in food access and affordability. In the
ABM, individual-agents in a virtual city make a series of daily decisions about where to shop for food, what
types of food to purchase, and what to eat. Each decision is based on simple rules that reflect influences on
food purchasing and diet, including household food budgets; travel costs to food stores; between-store
variation in price, inventory, and quality; and the prices of 12 nutritionally important food categories (e.g.,
protein, whole grains) and 6 beverage categories. We use gold standard data regarding household income and
food spending, food prices and purchasing, and diet. We propose two uses for the ABM: First, we will assess
the impact of job and income loss related to the COVID-19 pandemic and federal policies that restrict eligibility
and enrollment of immigrants in food assistance programs – both of which have a disproportionate effect on
minorities and thus are likely to exacerbate disparities. Second, we will engage policy stakeholders to inform
dissemination and evaluate how scaling up existing pilot programs (e.g., healthy food delivery, multiplying the
value of SNAP dollars spent at farmers’ markets, increasing healthy food access in minority neighborhoods)
and implementing current policy proposals (e.g., USDA proposal to replace SNAP with “harvest boxes”) will
exacerbate or reduce diet disparities. The ABM is grounded in the Philadelphia context, but the research
questions and findings are highly relevant to diet disparities in essentially all U.S. cities.

Public health relevance
PROJECT NARRATIVE We will systematically engage local policy, community, and academic stakeholders to develop and refine a dynamic conceptual framework that elucidates drivers of racial/ethnic disparities in diet in cities. We will also implement an agent-based simulation model to examine how high levels of racial/ethnic residential segregation in U.S. cities, the inequitable distribution of food outlets, pervasive income inequality, and the lower price of energy-dense, non-nutritious foods relative to healthier foods work in combination to constrain healthy food choices of racial/ethnic minorities and lead to disparities in diet and obesity. We will use the model to evaluate how inequitable job and income loss due to the COVID-19 pandemic will affect diet disparities, and how multiscale federal, state, and local policies can either exacerbate or reduce disparities.